Creating PK/PD models for oxytocin action in humans and bridging to intranasal delivery

Project 3 Summary
Surgery benefits most patients, but for some, it results in chronic pain and disability. Under current
funding, we have moved the state of research in this area forward by developing and applying methods to
more precisely map the speed of recovery in individual patients after surgery. In addition, we have shown that
recovery after surgery in animals and humans is quicker if surgery occurs around the time of delivery, and this
hastened recovery reflects oxytocin (OXT) actions. Although OXT’s effects on multiple neurologic disorders
have been probed in animals, translational testing in humans is hampered by a route of administration
(intranasal [i.n.]) with undetermined distribution in the brain or the periphery. Project 3 will build on these
observations and translate, with guidance by Projects 1 and 2 and support by the PK/PD Core, critical testing
of OXT’s actions on somatosensation and the sensory and affective dimensions of pain. Specifically:
Aim 1. Create PK models of OXT in plasma after IV and i.n. administration and test covariates
This Aim will determine oxytocin pharmacokinetics (PK) after IV and i.n. administration in plasma and
test whether key biologic variables (sex, age, weight, race, ethnicity) affect this disposition. These data will be
used to determine appropriate dosing to target sites of peripheral or central drug action, including pain relief.
Aim 2: Define OXT actions at peripheral sites of somatosensation
Using either pain report from a 5 minute heat stimulus or paradigms to be tested by our Swedish
collaborators (under their funding by the Wallenberg Foundation outside this P01), we will create and validate a
PK/PD (pharmacodynamic) model for OXT on somatosensation including pain in the periphery. This model will
guide OXT dosing under a subaward in Sweden to directly test the effects of OXT on sensory afferents using
microneurographic recording and by us to test the effects of OXT on light touch as well as pain fibers.
Aim 3: Validate hippus as a measure of OXT action and bridge IV studies to intranasal administration
We will for the first time establish a PK/PD model for oxytocin in the brain, using pupil diameter
oscillations (hippus) as an outcome measure. We will then apply knowledge from Aims 1 and 2 to create
PK/PD models for pain relief and central nervous system action after i.n. OXT administration. These models
will guide dosing for future clinical trials of i.n. OXT to treat pain and other neurologic disorders.

Public health relevance
Narrative Physical injury, including surgery, can cause chronic pain, but this is less likely around the time of childbirth, and initial work suggests this is due to a protective effect of the neurohormone, oxytocin. This project within the P01 will translate recent observations and laboratory work in the other projects to people. We will determine how oxytocin is distributed in the brain and the periphery after intravenous injection and use this to test how and at what sites it alters perceptions of light touch, vibration, and pain from pressure or heat or cold. We will finish with studies with intranasal self- administered oxytocin to apply the findings and prepare for clinical trials in the future.